Circuit-level neurodevelopmental trajectories of decision-making computations across adolescence

Project Summary
Adolescence is one of the most critical periods of neurodevelopment. The brain undergoes a profound
reorganization during this stage, including the formation and stabilization of neural circuits that control decision-
making. We, and others, hypothesize that age-related improvements in decision-making are driven by changes
in brain circuits that encode specific decision-making mechanisms. Direct evidence supporting this hypothesis,
however, has been limited. The prefrontal cortex in particular undergoes an intense restructuring during
adolescence and brain imaging studies have observed robust changes in the orbitofrontal cortex (OFC) and
anterior cingulate cortex (ACC). The OFC and ACC are altered in individuals with mental illness, which is thought
to be the mechanism underlying decision-making deficits that emerge in these clinical populations. When and
how these alterations occur is not known, but emerging evidence suggests developmental changes in subcortical
projections to the OFC and ACC may be involved. Here, we propose to use in vivo calcium imaging and
optogenetic techniques coupled with computational modeling, to longitudinally assess circuit and neuronal
activity in behaving rats at multiple adolescent ages to determine how developmental changes in OFC and ACC
networks mediate improvements in decision-making. In Aim 1 we will determine how encoding of attention and
reward-prediction errors in amygdala and ventral tegmental area (VTA) projections to the OFC improves across
adolescence in rats using a reversal-learning task. We will then use a new transsynaptic tracing approach in Aim
2 to demonstrate that attention and reward prediction errors controlled by amygdala and VTA projections are
integrated into OFC neurons to determine the degree to which action values are updated and strengthened
during adolescence. Finally, Aim 3 studies will investigate the role of OFC projections to the ACC in integrating
value updating with current action value estimates that guide adaptive decision making. Together, these studies
will provide key insights into the developmental mechanisms that guide complex decision making. Our normative
data will provide a framework for identifying and understanding the neurodevelopmental mechanisms of mental
illness, and inspire future translational studies.

Public health relevance
Project Narrative During adolescence the brain undergoes a profound reorganization, including the formation and stabilization of neural circuits that are critically involved in decision-making. Here, we use sophisticated in vivo methods to interrogate the functional developmental changes longitudinally across adolescence within a midbrain/amygdala- cortical neural network that mediates reinforcement-learning computations to guide value-based choice.